AUTONOMIC STIMULATION AND BLOCKADE ON THE SIGNAL AVERAGED ELECTROCARDIOGRAPHY

The purpose of this protocol is to evaluate the changes in QRS duration and other signal averaged ECG parameters associated with autonomic stimulation and blockade.